Elucidating Molecular Mechanisms of Gating Regulation and Subunit Modulation of N-glycosylation on Ion Channels by Using Molecular Dynamics Simulations

Individuals suffering from cognitive impairment, impaired Sleep, and muscle loss in advanced age are faced with the loss of independence, decreased healthspan, and increased financial burden. Understanding the glycomolecular mechanisms that instigate these impairments is of critical importance. This proposal examines how the accumulation of advanced glycation end products (AGEs) and their receptor (RAGE) contributes to the onset of these behavioral impairments throughout an animals lifespan to negatively impact healthspan.